NHLBI UIPATH LICENSES AND SUPPORT SERVICES

The purpose of this contract was to procure UiPath’s Robotic Process Automation (RPA) software, premium care, and support services. UiPath software will be used to establish an IC-wide RPA platform, and automate select processes.

NHLBI requires UiPath Software licenses and Premium Care to provide technical support throughout the period of performance to ensure success. Additionally, NHLBI requires support for a one-time effort to establish an Institute-wide UiPath RPA platform.